Tumor subregion and immune cell type-selective proteomic profiling

Project Abstract
A tumor is complex ecosystem in which cancer cells interact with diverse immune cells, creating a cancer-
supportive microenvironment. The locations of these immune cells within a tumor significantly affect their
functions, which are associated with cancer progression, metastasis, and response to therapy. We propose to
develop a novel spatial proteomics approach by integrating 3D microscopy techniques with bottom-up proteomic
assays, which can offer deep proteome profiles of specific immune cells at various subregions of a tumor. In Aim
1, we will develop a workflow involving 3D photobleaching-mediated spatial fluorescence encoding of immune
cells located in different subregions of a mouse tumor. In Aim 2, we will apply the spatial proteomics method to
identify macrophage niches associated with therapeutic responses in the tumor microenvironment. If successful,
this innovative approach will revolutionize our ability not only to understand the spatially associated functions of
immune cells in tumors but also to discover new immune cell niches as biomarkers and targets for accurate
diagnosis and effective therapy for cancers.

Public health relevance
Project Narrative The spatial and functional heterogeneity of immune cells within a tumor is a major obstacle in understanding and treating cancer. This project aims to develop a novel spatial proteomics method for accurately assessing the functions of various immune cell types based on their locations in the tumor microenvironment. With the successful completion of this project, we will have established a powerful tool that dramatically improves the depth and breadth of our knowledge on the roles of immune cells in tumors, thereby contributing to the development of highly effective strategies for cancer immunotherapy.